Texas A&M Center for Environmental Health Research (TiCER)

Pilot Project Abstract
The Texas A&M Center for Translational Environmental Health Research (TiCER) is a
major hub for the development and growth of health research on campus through
attracting faculty from multiple schools, colleges, and departments. In addition, TiCER
scientists play leading roles in ongoing environmental health programs including the
P42 Superfund Basic Research Program, the T32 Toxicology Training Grant in
Regulatory Sciences, and the Interdisciplinary Faculty of Toxicology (IFT). The Pilot
Project Program (PPP) plays a key role in many aspects of the center by stimulating
research in areas consistent with center goals and by funding novel studies conducted
by faculty not previously committed to environmental health research. The PPP is a
critical element in both the ongoing and future health research activities of the center as
is evidenced by the large number of applicants for PPP funding from multiple academic
units. In order to maintain and improve the PPP, four major Aims will be pursued: 1)
Maintaining a well-organized Pilot Project structure that will announce, disseminate,
receive review, and fund individual and collaborative projects in a timely fashion as
outlined in the grant application; 2) Attract junior faculty and investigators new to
environmental health research in order to expand this field and develop new
collaborations and themes; 3) Enhance collaborative research not only in “individual”
Pilot Projects but also through “collaborative grant” competitions; 4) Encourage inter-
Center collaborations that will involve faculty from more than one center as this will
further enhance the overall impact of proposed collaborative research.